MEASUREMENT OF CONTENT LAVAGE AND TRACHEAL ASPIRATE SAMPLES FROM NEONATES

The goal of this project is to analyze DPL and TA samples to identify the key mediators that initiate or control CLD. The hypthesizes is that DPL composition will differ significantly from TA composition, providing clues to key cytokines, cells and regulgatory elements involved in healing the distal airway and alveolar regions of injured, developing lungs. This is an offiste protocol using nursing support.